Developmental Biology of the Sea Urchin and Other Marine Invertebrates XXVIII (DBSUMI)

Project Summary
In April of 2025, an international community of scientists who use marine invertebrate model organisms for
reproductive, developmental, and regenerative biology will convene for the 28th Developmental Biology of the
Sea Urchin and other Marine Invertebrates (DBSUMI) meeting at the Marine Biological Laboratories in Woods
Hole, MA. Work in marine invertebrates has led to many important scientific advances, and this conference will
provide an essential forum for interactions across a broad community of investigators working with diverse
organisms. While originally conceived as the “Sea Urchin Meeting”, our meeting now comprises individuals
working with echinoderms, hemichordates, ascidians, mollusks, annelids, cnidarians, and more. We are
requesting funds to support DBSUMI in the following ways: 1) to support event space costs and A/V support,
and 2) to provide need-based reduced registration fees to trainees.

Public health relevance
Project Narrative This proposal is to support the 28th Developmental Biology of the Sea Urchin and other Marine Invertebrates (DBSUMI) meeting at The Marine Biological Laboratories in Woods Hole, MA. This conference will provide a forum for interactions across a broad community of investigators working with diverse biomedically-relevant marine invertebrate models, including echinoderms, hemichordates, ascidians, mollusks, annelids, cnidarians, and more.